Core 1: Adaptation, Dissemination, and Implementation Shared Resource Core

The overall objective of the AMPLIFI Adaptation, Dissemination, and Implementation (ADI) Shared Resource
Core (SRC) is to provide all AMPLIFI projects with the expertise and infrastructure required for intervention
adaptation, optimizing future dissemination and implementation (D&I), and identifying processes common
across all interventions that advance adaptation and D&I science. Although multiple randomized controlled
trials have tested the efficacy of interventions aimed at improving health behaviors after a cancer diagnosis
and treatment, translation of these interventions into standard practice and broader use is limited. Such
translation could be improved by developing an integrated approach to intervention adaptation to different
settings, subgroups, and distance-delivery strategies while improving intervention D&I potential. Mixed
methods research approach is well-recognized as crucial to the adaptation process and provides the rich data
needed to better understand adaptation and D&I strategies. Hence, the ADI SRC includes a multidisciplinary
team with collective expertise in adaptation, D&I science, mixed methods research, cancer survivorship, older,
rural and minority populations, technology-supported health behavior interventions, and health disparities. In so
doing, the ADI SRC will support all AMPLIFI projects and fill an important scientific knowledge gap related to
the “type 3 evidence” needed to better adapt and implement interventions. The ADI SRC specific aims are:
Primary Aim: Support each project by developing and maintaining an infrastructure for providing
methodological guidance, expert consulting and trained staff to ensure that investigators have ready access to
relevant resources, mixed methods data, and logistical support for measuring D&I related outcomes,
completing intervention adaptations, evaluation, and refinements, and finalizing implementation toolkits.
Secondary Aim 1: Assist project investigators in describing, categorizing, and tallying adaptations required
by each project (before and during implementation) to determine the most common adaptations needed for
different cancer groups, geographical locations, and distance delivery methods.
Secondary Aim 2: Assist project investigators in optimizing intervention D&I after project completion. This
will include but is not limited to identifying similarities and differences across the project interventions to
optimize D&I after project completion (e.g., D&I barriers and facilitators, relevant stakeholders and community
partners, and potential strategies and venues for improving future D&I of the adapted interventions).
Secondary Aim 3: Develop an adaptation model for guiding adaptations of health behavior interventions for
cancer survivors applicable across different health behaviors and types of distance-delivery methods.
The D&I outcomes data will be used to integrate recommendations for improving D&I potential into the model.
The ADI SRC's exceptional team of investigators and consultants will use a rigorous mixed methods approach
to optimize all AMPLIFI projects and innovatively integrate cross-project data to advance D&I science.

Public health relevance
PROJECT NARRATIVE The overall objective of the AMPLIFI Adaptation, Dissemination, and Implementation (ADI) Shared Resource Core (SRC) is to provide all AMPLIFI projects with access to the experts, resources, and data required to optimally adapt their interventions for cancer survivors (especially those that are older, rural residents, or minority) while retaining the key, essential elements of the interventions. The ADI SRC will also help all projects improve the potential that their intervention will be translated into broader use so that a greater number of cancer survivors can benefit from these interventions. While providing this support for all projects, the ADI SRC team will also collect and integrate information from all projects concerning the process of adapting the interventions that will help future beneficial interventions adapt and translate to broader use more efficiently.